Covert Cerebrovascular Disease Detected by Artificial Intelligence (C2D2AI): A Platform for Pragmatic Evidence Generation for Stroke and Dementia Prevention

Project Summary
Incidental imaging findings are common; an estimated 15-30% of all diagnostic imaging and 20-40% of CT
examinations contain at least one incidental finding. Comprised of both covert brain infarct (CBI) and white
matter disease (WMD), covert cerebrovascular disease (CCD) is a common incidental finding among adults
over 50 and is a risk factor for stroke and dementia. Our epidemiological work, leveraging a natural language
processing (NLP)-enhanced real-world cohort, indicates that incidentally discovered-(id-)CCD patients are at
two to three-fold the risk for future stroke and dementia, consistent with prior findings. Health systems have
rushed to comply with the 21st Century Cures Act Information Blocking Rule (hereafter “Rule”) which requires
immediate disclosure of id-CCD through release of radiology reports, often without the benefit of interpretation
by referring physicians. Prior to the Rule, only about 10% of patients were informed of CCD incidental findings.
Early reports suggest that incidental findings have contributed to heightened patient distress and increases in
workload for clinicians faced with more portal messages, referral requests, and calls to address incidental
findings. Yet, existing bioethical guidance related to disclosure of incidental findings is largely silent on this
issue, responsive instead to concerns raised by genetics/genomics and clinical research literatures, which
present unique considerations that are not directly transferrable to other routine care. Lack of guidance
regarding how to disclose incidental findings and support patients who discover new diagnoses absent patient
tailored education about the condition, risks, and potential treatment options underscores an important gap in
capacity pertaining to ethically disclosing incidental findings in routine care and developing supports for
patients and clinicians for patients with id-CCD, with generalizable findings for other patient populations. Our
preliminary findings underscore unmet needs and increasing demand for development of evidence-based
disclosure statements and educational materials to support patients and clinicians. This study addresses
ethical tensions for clinicians determining how to balance ethical obligations for transparency and patient
autonomy with obligations to protect patients from unnecessary distress. Our studies will complement the
Parent Grant and build capacity to improve practice guidelines and education for disclosure of id-CCD. We will
use data about patient and clinician preferences for disclosure, education, and engagement, to develop
patient-centered disclosure statements and an education toolkit to improve quality care for older adults with id-
CCD and their providers by clarifying how to best ethically disclose incidental findings, support patient
autonomy and engagement, and promote appropriate health care use.

Public health relevance
Project Narrative Need for ethical, evidence-based guidance about incidentally discovered covert cerebrovascular disease (id-CCD) disclosure has been compounded following The 21st Century Cures Act’s Information Blocking Rule (Rule), which granted patients immediate access to medical records, often without benefit of interpretation by patients’ treating physicians. Our studies will complement the Parent Grant and build capacity to improve practice guidelines and education for disclosure of id- CCD. We will use data about patient and clinician preferences for disclosure, education, and engagement, to develop patient-centered disclosure statements and an education toolkit to improve quality care for older adults with id-CCD and their providers by clarifying how to best ethically disclose incidental findings, support patient autonomy and engagement, and promote appropriate health care use.